2024 Ion Channels Gordon Research Conference and Gordon Research Seminar

Project Summary/Abstract
This proposal requests partial support for an internationally-attended meeting on Ion Channels, as part of the
Gordon Research Conference (GRC) series, to be held at Mount Holyoke College in South Hadley,
Massachusetts, July 7 – 12, 2024 which immediately precedes with a Gordon Research Seminar (GRS)
specifically aimed towards graduate students, post-docs, and early career scientists, to be held July 6-7, 2024,
at the same location. The broad and long-term goal of the conference is to increase our understanding of the
structure, function and physiological roles of ion channels, their targeting by next-generation therapeutics, and
the molecular basis of channel dysfunction in disease. The 2024 iteration of the meeting will convene leading
researchers to share unpublished, cutting-edge research on these proteins responsible for electrical signaling
and ion transport. Recent advances in structural biology, high-throughput experimental methods, and machine-
learning approaches can potentially revolutionize biological research. This edition of the meeting will highlight
how big data and other emerging approaches are providing new insights into the role of ion channels in human
physiology and diseases. Our diverse panel of speakers and discussion leaders will present the latest advances
in understanding the biology and mechanisms of ion channel structure, gating, regulation and drug action. The
specific aims of this meeting will be to assemble roughly 45 speakers and discussion leaders representing critical
areas of ion channel research, with a maximum total of 200 participants, for a five-day meeting in a secluded
setting. The program will have nine platform sessions that address current issues in ion channel mechanisms in
human health and disease, incorporating late-breaking talks to be determined shortly before the conference, to
promote discussion on the newest cutting-edge research. Ample time will be allotted during the platform sessions
for discussion and exchange of ideas. In addition, four poster sessions will allow all participants to present their
latest research and further scientific discussions. The significance of this proposal is that the Ion Channels GRC
is widely regarded as a key, established conference to fertilize ideas and research in the community of ion
channel biologists. Indeed, the small size and intensive discussions facilitated by the Ion Channels GRC make
it uniquely important for the catalysis of new ideas and directions among the participants. The goals of the
meeting are to advance our understanding of ion channels as key players in the function of nerves, muscles,
sensory organs, and other systems and as therapeutic targets for the cure and treatment of human disease.

Public health relevance
Project Narrative This proposal requests support for the Ion Channels Gordon Research Conference and Seminar (GRC/GRS), a meeting in which detailed presentations of the latest, state-of-the-art research on ion channels will be curated, and attendees will pursue detailed discussions and define questions of biomedical importance. Ion channels are important proteins that govern the electrical excitability of nerve, muscle, and endocrine cells, and their dysfunction leads to diseases that include epilepsy, paralysis, cardiac arrhythmia, and diabetes, making them targets for effective drug therapies. Ultimately, the discussions and research collaborations resulting from the Ion Channels GRC/GRS will pave the way for innovative approaches to treat various human diseases.